AI-Enhanced App-based Intervention for Adolescent E-cigarette Cessation

Project Summary Abstract
Electronic cigarette (e-cigarette) use among adolescents is an emerging public health problem. In 2020,
19.5% of high school students and 4.7% of middle school students used e-cigarettes, even though e-cigarette
use is known to be harmful to adolescent health, resulting in nicotine-related symptoms of addiction and
various other health issues (e.g., depressive symptoms), and is associated with use of other addictive
substances. In spite of the urgent need to address this issue, there is a lack of effective interventions for
adolescent e-cigarette cessation. Thus, effective and sustainable interventions to address adolescent e-
cigarette use are urgently needed. This study is aimed at creating a scalable e-cigarette use cessation
intervention using a smartphone application (app), which can be delivered to a large pool of adolescents. This
study will test and launch a scalable smartphone AI-enhanced app-based intervention delivery that can be
feasibly implemented in schools, primary care clinics, and community settings for adolescent e-cigarette
cessation. An artificial intelligence (AI)-enhanced smartphone app-based intervention is a cost-effective
strategy that facilitates personalized messages for behavioral problems. Using AI-assisted user profiling
techniques based on participants’ e-cigarette use status, patterns, other substance use status, readiness to
quit e-cigarettes, and beliefs about e-cigarettes, this intervention will send personalized content with
mindfulness-based training modules. Timely messages will be sent in response to users’ urges to use e-
cigarettes based on self-report in real time through the smartphone app. In addition, AI will be able to answer
app users’ questions via an automated chatbot. We will pilot test the intervention for summative evaluation
using a quasi-randomized controlled study using a delayed intervention design. In Phase 1, we will refine a
smartphone app-based intervention based on feedback obtained from participant interviews on usability
(functions, interface, and content), a usability survey, and a task performance test. In Phase 2, we will pilot test
the intervention using a quasi-randomized controlled study design. We will examine the usability via a usability
survey, and participants’ engagement on the app use via frequency of AI-app use (each feature), data entered
in the app, and minutes of app use per day. In addition, we will examine the e-cigarette cessation related
outcome changes of the app-based intervention by evaluating e-cigarette use frequencies compared to the
control group (3 month delayed intervention) in terms of quit rates at post-intervention, 30-days and 3-months
post-intervention; number of days e-cigarette used in the past 30 days; number of quit attempts; intention to
quit; readiness to quit; nicotine addiction; and beliefs and perceptions about e-cigarettes. We will examine the
feasibility of the intervention based on user experiences of functions, interface, content. Over the long term,
findings from this study will contribute useful information for those testing the effectiveness of smartphone app-
based interventions for adolescent e-cigarette use cessation on a large scale.

Public health relevance
Project Narrative This study proposes to finalize the development of a smartphone AI-app-based intervention for adolescent electronic cigarette (e-cigarette) cessation using a formative evaluation process and to pilot test the app as a summative evaluation. To achieve this, this study will attempt to develop and test a feasible, effective, scalable program using a smartphone application, which can be deployed to a large pool of adolescents through schools, primary care clinics, and community settings. Developing an AI-enhanced program is promising for addressing the emerging health threats of e-cigarette use among adolescents because such programs can provide individualized contents based on user profiling techniques and provide immediate help to manage cravings based on real-time recorded data.